Risk Factors of Gestational Diabetes

The overarching goal of this research agenda is to identify risk factors, in particular potentially modifiable factors that may contribute to the prevention of GDM. Research efforts in the past four years include nutritional, environment-chemical, and social-behavioral determinants that are implicated in glucose homeostasis. Within the common theme of insulin resistance and secretion, several important diet and lifestyle associations with GDM have been successfully identified in this effort based on data from the Nurses' Health Study II and the NICHD Fetal Growth Studies.

Dr. Zhangs research endeavor in identifying modifiable factors that may contribute to the prevention of GDM. Research efforts in the past four years include nutritional, environment-chemical, and social-behavioral determinants that are implicated in glucose homeostasis. Within the common theme of insulin resistance and secretion, several important diet and lifestyle associations with GDM have been successfully identified in this effort based on data from the Nurses' Health Study II and the NICHD Fetal Growth Studies.

The lead PI, Dr. Cuilin Zhang, departed from the NICHD in 2021.